Infectious Disease/Basic Microbial Pathogenic Mechanisms

DESCRIPTION (provided by applicant): This is an application to renew the Infectious Diseases/Basic Microbial Pathogenesis Training Grant from Washington University. With the advent of generally available antibiotic therapy 40-50 years ago, many physicians and scientists predicted the end of infectious diseases as a major area of health concern. Subsequent events have proven this prediction wrong, and the past decades have seen the emergence of many newly identified infectious diseases, including Lyme Disease, erlichiosis, SARS, West Nile encephalitis, avian influenza, and HIV, as major health problems. The reemergence of old infectious diseases, such as malaria and bacterial infections, in new more virulent and more antibiotic resistant forms also has increased public attention on the health problems posed by infectious diseases. The threat of microbial bioterrorism has also come to the forefront. It is rare that a week goes by without some troubling headline concerning new infectious disease outbreaks. Thus, far from gradual disappearance as a health concern, infectious diseases have emerged in the past decade as being of even greater importance to the health concerns of the nation than previously. The emerging antibiotic resistance of current pathogens, the discovery of new disease agents, and the specter of bioterrorism have made clear the necessity of increased fundamental scientific investigation into all aspects of infectious diseases. The purpose of the Washington University Training Program in Infectious Diseases/Basic Microbial Pathogenesis is to help fulfill this need by recruiting promising young investigators to this field and training them in outstanding research programs with preeminent investigators who collaborate across multiple disciplines (or who function in interdisciplinary teams) to perform infectious disease research. Our Training Program, which has had NIH support for the past 25 years, integrates faculty from four departments: Medicine, Pediatrics, Molecular Microbiology and Pathology &Immunology. The program provides training to M.D., Ph.D., and M.D./Ph.D. postdoctoral fellows, and to Ph.D. and M.D./Ph.D. students, in disciplines related to pathogenesis and host defense in Infectious Diseases. The laboratories of the program preceptors use tools of molecular biology, biochemistry, genetics, genomics, immunology, and cell biology. The clinical research component includes epidemiology, biostatistics, clinical trials, outcomes research, health economics, health behavior research and informatics tools and methods to train patient-oriented and translational researchers. Thus, the program trains young investigators to be able to answer the important questions of microbial pathogenesis, from studies of basic biology through application to the bedside.